Overall 3

Core C - Protein Expression and Purification Core The success of the entire Program of Projects hinges on the availability of large amounts of protein reagents as well as on the ability to rapidly clone, express and purify a very diverse set of mutant proteins. For example, hundreds of milligrams of core histones and histone chaperones will be required for the proposed research. Additionally, the Projects demand the flexibility to prepare smaller amounts of specific mutants and truncations of histones and chaperones. Specifically, these reagents will be required for the studies on histone acetylation patterns, histone chaperone interactions, nucleosome dynamics and regulation of higher order chromatin structures. Smaller quantities of highly pure histone chaperones, histone acetyl transferases, transcription factors and coactivators will also be needed. Rigorous quality control of the shared reagents will ensure maximum reproducibility for the research in the three Projects. The Protein Expression and Purification (PEP) Core is fully equipped for the high-throughput preparation of large amounts of proteins. The Director, Dr. Karolin Luger, and the Associate Director, Teri McLain, have many years of experience in the large-scale and small-scale purification of a large variety of proteins. The PEP CORE has the following specific aims: Aim 1: Express and purify histones from E. coli Aim 2: Express and purify histone chaperones from E. coli and baculovims-infected Sf9 cells Aim 3: express and purify histone acetyltransferases Aim 4: Express and Purify Activators and Accessory Proteins Aim 5: Extract and Purify Endogenous Proteins from Tissue and Cells Aim 6: Maintain an Up-To-Date Inventory of All Protein Produced by the PEP CORE in the Chromatin Intranet Website

Public health relevance
A centralized facility that efficiently produces large quantities of biologically-relevant proteins will significantly enhance the progress of each Project described in this application.